Simultaneous Optical Voltage Imaging and fMRI in Behaving Mice

Abstract
Among the various areas in brain research, brain imaging is the most appreciated by a general audience. Due
to recent advances in imaging technologies, we can “see” brain in action. One of the most promising and
widely used noninvasive imaging technologies is functional Magnetic Resonance Imaging (fMRI) based on the
Blood Oxygenation Level Dependent (BOLD) contrast. However, the physiological basis of this technique is
still poorly understood. Electrical recordings and in vivo 2-photon calcium imaging have enabled us to
understand functions of identified neuronal populations. A major challenge of today is to connect these
microscopic neuroscience insights, which require invasive imaging and recording tools, with macroscopic
noninvasive fMRI signals.
To address this challenge, I propose to combine optical imaging of electrical neuronal activity
simultaneously with BOLD fMRI measurements in awake behaving mice. These experiments will leverage
an MRI-compatible optical imager that I have engineered and integrated into an animal holder since the first
submission (the old Aim 1). In the new Aim 1, I will explore the relationship of cell-type-specific neuronal
voltage and BOLD fMRI signals during spontaneous and task-induced neuronal activity. The BOLD signal can
be both positive and negative, and previous findings from my lab demonstrate the importance of a specific
population of cortical inhibitory neurons that release a signaling molecule Neuropeptide Y (NPY) causing
vasoconstriction via Y1 receptors. In the new Aim 2, I will address the role of NPY-positive neurons in
generation of BOLD signals. To this end, I will combine voltage imaging and BOLD fMRI with optogenetic
silencing of NPY-positive neurons and antagonizing the NPY-Y1 pathway.
From a technological perspective, my study will be the first to perform voltage imaging inside an MRI scanner.
On the biological side, my study will provide empirical data addressing the relationship between cell-type-
specific neuronal activity and the BOLD signal and evaluate the dependence of a specific macroscopic imaging
signal – negative BOLD – on a concrete cellular/molecular pathway. While working on my dissertation project, I
will expand my scientific knowledge base, produce high-profile publications, and build a foundation for my
future career as an independent investigator.

Public health relevance
Narrative Due to recent advances in imaging technologies, we can “see” brain in action. My dissertation project is aimed at understanding the signals generated by one of the most widely used brain imaging technologies – functional magnetic resonance imaging – in terms of the underlying microscopic activity of brain’s neurons and communication between neurons and cerebral blood vessels. This scientific knowledge will contribute to understanding of mechanisms regulating cerebral blood flow.